Metabolic tagging of tumor exosomes for developing enhanced exosome vaccines

SUMMARY
Immunotherapies have shifted the paradigm for cancer treatment in the past decade. Among them, therapeutic
cancer vaccines, consisting of tumor antigens and adjuvants for activating antigen presenting cells (e.g., dendritic
cells (DCs)), have shown the promise to elicit persistent humoral and cytotoxic T lymphocyte (CTL) response,
but are limited by the modest therapeutic benefit. Hurdles for developing potent cancer vaccines include the lack
of available tumor antigens and sub-optimal modulation of DCs. Tumor-derived exosomes, the nano-sized
extracellular vesicles secreted by tumor cells, are a good source of tumor antigens and have been widely
explored as cancer vaccines in preclinical studies and clinical trials. However, the antitumor efficacy is far from
satisfactory, likely as a result of poor CTL response. The incorporation of adjuvants that can bind to the toll like
receptors on DC membrane and thus activate DCs has become standard practice for improving conventional
vaccines, but simple mixing with adjuvants has failed to enhance the antitumor efficacy of tumor exosome
vaccines. The primary goal of this project is to develop a strategy that can well integrate tumor exosomes and
adjuvants for the development of potent tumor exosome vaccines. To achieve this, we utilize a metabolic glycan
labeling approach to label glycoproteins and glycolipids on the membrane of cancer cells with chemical tags
(e.g., azido groups), and hypothesize that exosomes secreted by these labeled cancer cells will carry chemical
tags on the surface. The chemically tagged tumor exosomes can covalently capture adjuvants and other
immunomodulatory agents via efficient and bioorthogonal click chemistries, potentially resulting in improved
activation and antigen presentation of DCs and enhanced CTL response. This project will be organized around
two specific aims. In Aim 1, metabolic glycan labeling of various types of cancer cells for the generation of azido-
labeled exosomes will be explored. Two hypotheses will be tested in this aim: (1) azido-labeled tumor cells can
secrete azido-labeled exosomes; (2) the azido groups on the surface of exosomes can efficiently conjugate
dibenzocyclooctyne (DBCO)-molecules via click chemistry. In Aim 2, adjuvant-conjugated tumor exosomes will
be explored as therapeutic cancer vaccines, with the resulting CTL response and antitumor efficacy evaluated
in murine breast cancer and glioblastoma models. Tumor exosomes conjugated with both adjuvants and DC-
targeting ligands (e.g., anti-DEC205) will also be developed and evaluated. Successful completion of the
proposed studies not only will provide a generalizable technology to generate chemically tagged exosomes from
tumor cells for tracking and targeting purposes, but will also result in the development of potent tumor exosome
vaccines with great potential for clinical translation.

Public health relevance
NARRATIVE Tumor-derived exosomes have shown the promise to elicit humoral and cytotoxic T lymphocyte (CTL) response in preclinical studies and clinical trials, but the antitumor efficacy is still very limited. The primary goal of this project is to develop a generalizable technology for generating chemically tagged exosomes from tumor cells and further develop adjuvant-conjugated exosomes with enhanced CTL response and antitumor efficacy.